RASTER IMAGE CORRELATION SPECTROSCOPY (RICS): TRAINING AND APPLICATION

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The main aim is to learn RICS. With RICS, we are going to study the dynamics of the labeled lipid molecules and proteins in the close proximity of the golden petal structures.